The ANTIDOTE Institute- Advancing New Toxicology Investigators in Drug abuse and Original Translational research Efforts

PROJECT SUMMARY/ABSRACT
This proposal is responsive to PAR-21-320 with two overarching goals: 1) to provide empiric training in
research methodology and hypothesis-driven research, and 2) to train a diverse cadre of clinical medical
toxicologists as independent researchers at the intersection of substance use disorder (SUD) and public
health. The epidemics of SUD are in sore need of innovation and diversity among researchers. Medical
Toxicology is a field of medicine dedicated to the evaluation and treatment of poisoned patients, including
adverse health effects of drugs and illicit substances. Medical toxicologists have a track record of innovation
and public health-relevant research in SUD; however, few pursue careers as independent, federally funded
investigators. In response to this gap in our specialty, we developed in collaboration with the American
College of Medical Toxicology, a hybrid research mentorship program, the ANTIDOTE (Advancing New
Toxicology Investigators in Drug abuse and Original Translational research Efforts) Institute. The ANTIDOTE
Institute provides structured research methodology training and mentorship to medical toxicologists with a
long-term goal of developing a pipeline of medical toxicology physician scientists that achieve independent
federal funding in SUD research. This R25 proposes to formalize ANTIDOTE by extending our curriculum for a
more rigorous training experience, providing seed funding to accelerate the progress of institute fellows in SUD
research, and expanding institute activities to include outreach and multi-generational mentorship. The
expanded two-year ANTIDOTE curriculum will be delivered using a hybrid approach including in-person
retreats, virtual group meetings/didactics, and virtual one-on-one meetings. We have assembled a strong multi-
disciplinary faculty who are experts in research methodology, innovators in the care of SUD, and master
educators. The Specific Aims of this proposal are: 1) To expand, implement and widely disseminate the
ANTIDOTE institute with a curriculum grounded in Participatory Learning Theory to support the development of
toxicologists as clinician scientists: 2) To evaluate the impact of the ANTIDOTE institute using a validated
program evaluation tools: and 3) To facilitate and sustain the development of a diverse investigator pipeline in
medical toxicology, through training in mentorship skills, knowledge translation and outreach. The ANTIODTE
Institute is the first program of its kind to systematically address educational gaps within medical toxicology
training around developing hypothesis-driven research investigations. Successful expansion of the program will
facilitate methodologically rigorous and clinically informed research on SUD and create a national network of
diverse investigators to sustain this momentum. This framework can then be translated outside of the field of
medical toxicology to facilitate pipeline development in other clinical specialties.

Public health relevance
NARRATIVE Medical toxicologists have increasing roles in the management of poisoned patients, adverse drug events, novel therapeutics and substance use disorder (SUD). Despite their critical role in the care of patients with SUD, few medical toxicologists achieve federal funding or receive formal instruction in hypothesis driven research. This proposal establishes the Advancing New Toxicology Investigators in Drug abuse and Original Translational research Efforts (ANTIDOTE) Institute in collaboration with the American College of Medical Toxicology to facilitate research methodology skills in medical toxicologists interested in substance use disorder research.